Administrative & Biostatistics

PROJECT SUMMARY (See Instructions): The Administrative & Biostatistics Core will manage the budgetary, administrative and communication aspects of this U19. The Core will be responsible for coordinating meetings and interactions among investigators, transmitting data, communicating with NIH program personnel, preparing publications and maintaining a bibliography describing work performed, and all relative financial matters. The Financial Manager will act as liaison with the hospital's financial office, office of research affairs and materials management. In addition. Dr. Schoenfeld, Director of the MGH Biostatistics center, will assist with study design, sample size calculations, and data analysis.

Public health relevance
This Core will manage all the budgetary & administrative functions ofthe program, as well as the statistical analysis for all projects.